Nutrition for Precision Health, powered by the All of Us Research Program: Research Coordinating Center

Contact PD/PI: GANTZ, Marie G.
PROJECT SUMMARY/ABSTRACT
From Proposal:
The overarching goal of the RTI International–Cornell Research Coordinating Center (RCC) is
to provide seamless operational support and multidisciplinary experience for building consensus
in the Nutrition for Precision Health Consortium (NPHC). In the 1-year planning phase, we will
prioritize efficiency and objectivity in facilitating the design of diet modules (1: usual dietary
assessment; 2: controlled feeding dietary intervention; and 3: domiciled dietary intervention)
nested in All of Us and their research protocols. In the 4-year implementation phase, we will
facilitate the implementation of Modules 1–3, enable the flow of quality data and specimens
across the NPHC, and integrate curated, Artificial intelligence (AI)–ready data into the All of Us
Researcher Workbench, using our established data coordination processes and systems.
Innovations in our approach include tools for conducting dietary studies in hard-to-reach
populations, idiographic (or subject-as-own-control) clinical trials, and wearables research tools
and analytics. Specifically, the proposed RCC will excel in administrating and coordinating
NPHC and its research initiatives, clinical interventions, and data and biospecimen sharing, as
follows:
Aim 1: Optimize the scientific rigor of Modules 1–3
Aim 2: Ensure NPHC study data are FAIR (Findable, Accessible, Interoperable, and
Reusable)
Aim 3: Enable seamless data collection, curation, and transfer including to the Researcher
Workbench
Aim 4: Minimize time to launch of Modules 1–3
Aim 5: Maximize the efficiency of consortium communications and collaborations
NPHC is being launched to address major research gaps in nutrition; the nature of these gaps
and the complexity of the NPHC activities cannot be underscored enough. RCC will be led by
Multiple Principal Investigators with complementary expertise in coordinating center and
multisite leadership and biostatistics (Dr. Gantz at RTI) and nutritional intervention and clinical
expertise (Dr. Mehta at Cornell University) with the support of a team organized around cores
for Design and Analytics, Data Curation and Systems, and Study Implementation. Other key
components include single IRB and medical safety monitoring. The RCC will also benefit from
our collective institutional strengths, with an expert pool of wide-ranging research and clinical
backgrounds pertinent to the NPHC (e.g., omics, bioinformatics, AI, clinical trial intervention,
nutritional assessment). The proposed RCC is immediately and amply prepared to support to
NPHC in its mission to develop clinically meaningful algorithms that predict individual responses
to food and dietary patterns and to improve health across the U.S. population.
Project Abstract

Public health relevance
Contact PD/PI: GANTZ, Marie G. Project Narrative From Proposal: As the Research Coordinating Center (RCC) RTI International will provide objective support and a strong infrastructure, built on a long history of multisite study administration and coordination, to the Nutrition for Precision Health Consortium (NPHC). The RCC will optimize the scientific rigor, data standards and management, implementation of nutrition interventions, and communication in facilitating NPHC, empowered by the All of Us Research Program, to inform strategies that improve nutrition guidance and health across the U.S. population. Project Narrative